CHILDHOOD CANCER DATA INITIATIVE: CLINICAL TRIAL SPECIMEN MOLECULAR CHARACTERIZATION (CTSMC) PROGRAM

The Clinical Trial Specimen Molecular Characterization (CTSMC) initiative will further the CCDI’s goals by providing molecular characterization of specimens from pediatric and AYA patients enrolled to NCI-funded clinical trials conducted by the PBTC, PEP-CTN, Pediatric CITN, and Children’s Oncology Group for use in the conduct of the trials and related correlative science studies.